Bridging preclinical and clinical trials in Alzheimer's disease through predictive modeling of cerebrospinal fluid proteomics

Neurofibrillary tangles (NFTs) of the microtubule-associated protein tau are a universal feature of the aging brain.
The extent of tau pathology throughout the brain correlates with both synapse loss and severity of cognitive
impairment in age-related tauopathies. The ability to maintain cognitive function with a brain accumulating NFTs
relies on the preservation and maintenance of synaptic networks. Therefore, understanding the mechanism by
which tau contributes to network and synapse vulnerability is critical for developing preventative therapeutics.
The goal of this proposal is to determine the cellular mechanism(s) by which pathologic tau drives neuronal
network dysfunction. The experiments proposed in this application will uncover these mechanisms and provide
intellectual and technical training for a successful transition into a postdoctoral position. The F99 phase (Aim 1)
will test mechanistic cell biological hypotheses to better define how abnormal tau accumulation induces synaptic
dysfunction, while providing opportunity to develop intricate experimental design and execution skills through
cutting-edge biochemistry, microscopy, and electrophysiology techniques. The K00 phase (Aim 2) will build upon
the F99 studies with computational strategies to integrate proteomics data from humans and experimental
models to identify co-existing molecular changes that are highly relevant to age-related tauopathies.

Public health relevance
As the human population ages, the ability to maintain cognitive function with a brain accumulating tau pathology relies on the preservation and maintenance of synaptic networks. Therefore, understanding the mechanism by which tau contributes to network and synapse dysfunction is critical for developing preventative therapeutics. This proposal aims to determine the cellular mechanisms(s) by which pathologic tau drives neuronal network dysfunction and propose a training plan catered to the applicant that will promote success as an independent researcher in the field of aging research.